Objective measures of sleepiness and cognitive function in different symptom subtypes of OSA

ABSTRACT
Obstructive sleep apnea is an extremely common condition that contributes independently to multiple
adverse outcomes, including cardiovascular disease, diabetes, and neurodegeneration. It is a major public health
problem given its high prevalence. OSA is heterogeneous, with established differences in symptoms and
outcomes in individuals with comparable disease severity based on traditional metrics. We were the first to show
that there are different symptom subtypes of OSA using unsupervised clustering analysis, including groups
defined by disturbed sleep with symptoms of insomnia, minimal symptoms, and marked excessive sleepiness.
The existence of these subtypes has since been replicated around the world in multiple population-based and
clinical cohorts. We have also shown that there are differences in outcomes between the these subtypes,
particularly for cardiovascular events and mortality, with increased risk in the excessively sleepy subtype.
However, there are still many unanswered questions. To begin to address these unanswered questions, we
propose to use data from the STAGES study, which recruited patients undergoing sleep studies across six sleep
centers in the United States and Canada. Participants had in-depth phenotyping that included: detailed
questionnaires about their sleep and health, depression and anxiety scores, actigraphy to assess sleep duration
over a 2-week period, psychomotor vigilance test to assess sleepiness objectively, and a comprehensive battery
of tests to assess cognition. In this project, we will first examine if there are differences in objectively-measured
sleepiness among the symptom subtypes, i.e., are individuals who complain of sleepiness also objectively
sleepy? We will also assess what role chronic insufficient sleep (based on actigraphy) and poor sleep quality
(based on a new measure of sleep depth—the Odds Ratio Product) play in determination of symptom subtypes.
Next, we will expand knowledge regarding the clinical relevance of these subtypes by evaluating differences in
neurocognitive outcomes. We hypothesize that the excessively sleepy group will have worse cognition than the
other groups, after controlling for key covariates. Finally, we hypothesize that objective data on sleepiness, sleep
duration, and sleep quality can be used to better understand additional heterogeneity among subjects with OSA.
Specifically, we will perform unsupervised clustering based on both subjective symptoms and objective
measures of sleepiness and sleep behavior (e.g., sleep duration and quality). We predict that we will identify
new subgroups of subjects and will assess whether there are larger differences in neurocognitive outcomes
among these subtypes when compared to subtypes defined only by subjective symptoms. The rich phenotype
data in STAGES allow us to address all of these important questions. Overall, this project is aimed at further
defining the heterogeneity of obstructive sleep apnea, an essential step in development of more personalized
approaches to diagnosis and management. Future directions for this study will include follow-up analyses in
other cohorts to validate the results and assess impact on other health outcomes.

Public health relevance
LAY NARRATIVE Obstructive sleep apnea is a common disorder and there is evidence that there are differences between patients with this disorder that are not explained by traditional measures of disease severity. Clinical subtypes based on patient-reported symptoms have been identified and validated. This project uses existing data to determine how objective measures of sleepiness, sleep duration, and sleep quality differ among these subtypes, as well as how subtypes based on subjective and/or objective data differ in cognition.